Recent Advances in HIV Research

PROJECT SUMMARY/ABSTRACT
Since 1998, the NIH-funded Centers for AIDS Research (CFAR) have hosted an annual one day National
CFAR Scientific Symposium in conjunction with the annual CFAR Directors’/Administrators’ meeting. The
purpose of the CFAR scientific symposium is to present, in a public forum, recent “cutting edge” advances in
HIV research for an average attendance of approximately 250-300. Whenever possible, topics will reflect
issues related to the OAR HIV/AIDS Priorities. The intimate size of the meeting promotes opportunities for
interactions between young and more senior investigators that would not be available at the larger annual
scientific meetings related to HIV/AIDS. A key innovation in the last ten years is the addition of a peer
mentoring workshop for attending early-stage investigators. The meeting location rotates so that it is hosted
each year by a different CFAR site. This provides geographic diversity for the venue and opportunities for a
broader array of participants than for similar research symposia. As in the past, each hosting CFAR site has
the flexibility to design the scientific agenda of the conference to meet the current interests and needs of the
CFAR scientific community. Each hosting CFAR will ensure that there is representation of individuals from
diverse backgrounds across the selection and the makeup of the organizing committee, speakers, invited
participants, and, in particular, the selected early-stage investigators receiving travel scholarships from this
grant.
Speakers are selected from the various NIH-funded Centers for AIDS Research leadership, their scientific
membership, and from nationally and internationally recognized research institutions. In addition to the
participating CFAR Directors and invited leaders in the field, the remaining participants for the annual National
CFAR Symposia are chosen based on specific criteria. First preference is given to young investigators who
have received developmental funds from an NIH-funded CFAR program; second preference to young
investigators with demonstrable potential in HIV/AIDS research; third preference is to other senior investigators
engaged in HIV/AIDS research. In all cases women and individuals from underrepresented ethnic groups are
encouraged to attend through targeted advertising and travel scholarships. Access to childcare is provided by
the hosting CFAR and webcasts of the symposia are available for interested investigators who are not able to
attend.

Public health relevance
NARRATIVE The purpose of the Centers for AIDS Research (CFAR) Symposium is to provide a venue to present and discuss recent advances in HIV research. This is a unique forum for presentations of the most “cutting edge” HIV research topics. The symposium provides an environment that fosters interactions between senior HIV investigators and early-stage investigators that will one day be leaders in the field.